ATF4 As A Driver of T Cell Inefficacy in Tumors

PROJECT SUMMARY
Programmed cell death protein 1 (PD-1+) tumor infiltrating T cells (TILs) are a subset of T cells in tumors enriched
for tumor antigen specificity, and a-PD1 immunotherapy aims to reinvigorate PD-1+ TILs to act against solid
tumors. However, PD-1high CD8+ TILs are characterized by terminal exhaustion and poor bioenergetics marked
by depolarized mitochondria; therefore, only ~20% of cancer patients across tumor types respond to a-PD-1
therapy, limiting ubiquitous FDA approvals. Multiple stressors such as persistent antigen, hypoxia, and nutrient
stress converge to drive CD8+ TIL terminal exhaustion. Thus, identification of a common pathway that programs
the response to multiple forms of T cell stress could provide a potent target to reverse TME-mediated dysfunction
of the tumor-antigen specific population. Our group demonstrated that CD8+ TILs experience persistent stress
through chronic activation of the endoplasmic reticulum (ER) stress sensor PKR ER-like kinase (PERK). PERK
signaling drove CD8+ TIL activation and metabolic exhaustion in mouse and human PD-1high CD8+ TILs, and
inhibition of PERK induced complete and long-term responses to a-PD-1 therapy in sarcoma bearing mice. New
PERK inhibitors that bypass pancreatic toxicity are in development, but first-generation PERK inhibitors induce
toxicity in animals due to loss of the acute response. The long-term goal of the parent research program is to
identify new molecular targets in the chronic PERK axis that signal cell stress in CD8+ TILs in solid tumors,
limiting response to a-PD-1 immunotherapy in sarcoma patients. The goal of the supplemental project is to
expand preliminary data that identify that chronic PERK target activating transcription factor 4 (ATF4) instigates
cell stress and dysfunction in PD-1high CD8+ TILs. The supplemental project will test the central hypothesis that
ATF4 promotes aberrant activation and exhaustion in CD8+ TILs to undermine T cell function in multiple tumor
types, limiting response to a-PD-1 immunotherapy. This project directly aligns with the career development goals
of the candidate, Coral del Mar Alicea Pauneto, who aims to gain expertise in immune oncology in her graduate
work to achieve her long-term goal of enhancing access to cutting-edge tumor immunotherapies for
underrepresented minority populations.

Public health relevance
PROJECT NARRATIVE Solid tumors present conditions of extreme metabolic distress to tumor infiltrating T cells (TILs), and our group found that CD8+ TILs experience tumor stress through persistent engagement of cell stress sensors. The parent research program aims to define deleterious or beneficial roles for three specific mediators of the cell stress response in T cells to improve immunotherapies for sarcoma patients. The supplemental project aims to extend our proposal to test that tumor-mediated induction of a particular mediator severely disables T cell control in multiple cancer types, presenting a universal target to optimize the efficacy of immunotherapy for solid cancer patients.